Core C - Behavior and Electrophysiology Core

PROJECT SUMMARY/ABSTRACT – Behavior and Electrophysiology Core
The Behavior and Physiology Core will subject mice to a battery of assessments of
neurologic function including behavioral and cognitive tasks, In addition, the Core will
assess electrophysiologic parameters of hippocampal neurons in live mice and in ex
vivo hippocampal slices. The use of a Core facility for these studies will ensure the
involvement of trained personnel, standardized procedures, and standardized data
analyses and so will facilitate comparability across projects. All Core personnel will
undergo the same training so all mice will be exposed to the same handling.

Public health relevance
PROJECT NARRATIVE – Behavior and Electrophysiology Core This Core will perform the assessments of behavioral and cognitive function and hippocampal electrophysiology of mice for Projects 1 and 3.